Nanocrystal Quantum Dot Biomimetics of SARS-CoV-2 to Interrogate Neutrophil-Mediated Neuroinflammation at the Blood-Brain Barrier

PROJECT SUMMARY/ABSTRACT
Public/health/relevance: Chronic, or recurring, neurological deficits in 60% of recovered COVID-19 patients
are now an unmet medical need to treat the aftermath of SARS-CoV-2 infection of the central nervous system
(CNS). A recent study from Germany suggests that these symptoms persist beyond a year, similarly to patients
suffering from chronic symptoms due to SARS-CoV-1 infection. Thus, there is clear need for interventions
against chronic neurologic symptoms after COVID. Elucidating the mechanism for SARS-CoV-2 impact on the
CNS is essential to inform the design of such interventions.
Objective: This proposal aims to identify a pathway for SARS-CoV-2’s effects on the CNS through a
dysregulated blood-brain barrier (BBB) mediated by a neutrophil-dependent “storm” of bradykinin (BK). We
hypothesize that this storm induces neuroinflammation that ultimately disrupts normal neuronal signaling,
providing the substrate for enduring neurological symptoms.
Research Plan: Recent studies have reported altered integrity of the BBB in response to the spike (S) protein
of SARS-CoV-2, thereby suggesting a neuroinvasive pathway for SARS-CoV-2 or inflammatory immune cells
through the BBB. In line with these observations, this proposal will investigate how pro-inflammatory mediators
associated with COVID infection activate neutrophil-mediated upregulation of BK; this leads to an increased
permeability through paracellular gaps across the BBB due to dysregulated tight junctions (TJs). Such a model
aligns with the upregulated levels of BK observed in bronchoalveolar fluid taken from COVID-19 patients coupled
with the ability of neutrophils to engage the kinin system to remodel endothelial barriers in acute inflammation.
As a proxy for native SARS-CoV-2, we will construct S protein coated quantum dots as high fidelity biomimetics
of SARS-CoV-2 to investigate the size and structural constraints regulating SARS-CoV-2 permeability across
the BBB. These constructs will be used to bias neutrophils to a pro-inflammatory state in the presence of relevant
kallikrein-kinin factors to increase the permeability of cultured bEnd.3 monolayers, a high-fidelity in vitro model
system for murine BBB. A leakier BBB will be indicated by increased permeability of our fluorescent SARS-CoV-2 biomimetic and corroborated with complementary measurements of global barrier health, as measured by
transendothelial electrical resistance (TEER). Lastly, we will construct a correlated scanning ion conductance
and confocal microscope system to examine the heterogeneity of dysregulated barrier function and the specific
nanoscale changes in TJ expression and localization that regulate it.

Public health relevance
PROJECT NARRATIVE After initial onset of SARS-CoV-2 infection, at least 60% of COVID-19 patients exhibit chronic, “long-COVID” complications including neurologic disease that may persist for longer than a year, thereby greatly impacting an individual’s quality of life. A clear model for how SARS-CoV-2 infection impacts the central nervous system is needed to adequately design interventions against this type of disease. In this proposal, we will explore a mechanism that may explain the ability of SARS-CoV-2 to damage the blood-brain barrier to impact the central nervous system to aid in the design of such interventions.